Comprehensive Analysis of Peptide Motif Binding In Vivo

Project Summary/Abstract PI/PD: Pryciak, Peter M.
The proper function of cells depends on an enormous number of interactions between different proteins.
Interactions that are weak and transient are especially important in controlling molecular events that are rapid
and dynamic. In many cases these transient interactions are mediated by three-dimensionally folded protein
domains in one partner protein that bind to short peptide sequences in the other partner. These peptide
sequences are known as Short Linear Motifs, or SLiMs, and among human proteins there are over 200 distinct
families of SLiM-binding domains and many hundreds of examples. SLiM-mediated interactions serve critical
roles in subcellular localization, assembly of dynamic multi-protein complexes, and substrate recognition by
post-translational modification enzymes such as kinases, phosphatases, ubiquitin ligases, etc. While some
examples have been studied intensively, for the vast majority of SLiM-binding domains the key sequence
features that govern recognition of their target motifs are poorly defined. Moreover, over 3 million residues of
the human proteome are predicted to be structurally disordered and hence are likely to contain many as-yet
undiscovered SLiMs. This proposal seeks to illuminate the molecular basis of SLiM-mediated interactions and
fill current knowledge gaps. The experiments will develop a method for rapid quantification of relative binding
strength for thousands of variant peptide motif sequences, and a systematic interrogation of SLiM sequence
features that control their recognition and potency. The approach will use an intracellular functional assay that
can define SLiM recognition rules for a wide variety of globular domains, provide a relative affinity ranking for
large numbers of candidate motif sequences, and even identify competitive inhibitor peptides that can inform
drug design. One goal will be to validate the methodology by establishing the correlation between functional
potency and biochemical affinity, and the dependence of SLiM residue preferences on the surrounding peptide
context or strength. These experiments will also seek to expand the range of binding affinities that can be
resolved by the method. Another goal will be to apply the method toward a large number of SLiM-binding
domains to characterize their sequence preferences and independently confirm large numbers of binding
peptides identified in separate screens. A third goal will be to develop additional adaptations of the method that
will allow for the design and optimization of peptide-based inhibitors and tethering molecules for linking
together distinct domains inside cells. Overall, these studies will contribute to our general understanding of
protein-protein interactions, with relevance to the mechanisms underlying normal cell function as well as
disease states including the hijacking of SLiM-binding domains by human pathogens.

Public health relevance
PROJECT NARRATIVE This proposal seeks to shed light on the fundamental mechanisms by which proteins interact with each other in order to control the flow of regulatory information in the cell. The project uses yeast as a model system to study how protein domains recognize and bind to short peptide sequences in their interaction partners, which is central to the function of signaling proteins and protein modifying enzymes throughout eukaryotic biology, from yeast to humans. The resulting discoveries about the recognition rules and specificity determinants that control the binding of short peptide sequences will further our understanding of cellular regulation mechanisms relevant to human health and pathology, such as tissue differentiation, neoplastic growth, and drug design.